Pathogenic Mechanism and Therapeutic Approaches for Exercise Intolerance in Post-Acute Sequelae of COVID-19

Post-acute sequelae of COVID-19 (PASC) is an emerging public health priority with up to 18% prevalence.
Noteably, almost 30% patients diagnosed with PASC experence exercise intolerance. This activity limitation
continues to negatively impact our workforce, and poses a persistent socialeconimic burden on our society. Our
Post-Covid Recovery Clinic, a RECOVERY Vital site, has evaluated exercise intolerant PASC for nearly 4 years.
We recently discovered pathophysiologic endotypes that contribute to exercise intolerance in PASC via invasive
cardiopulmonary exercise testing (iCPET). Yet, the molecular drivers for this population remain elusive. Four-
years after the onset of the pandemic we are left without PASC-defining biomarkers, or targeted therapeutics.
Thus, it is crucial to investigate the interconnected molecular and pathophysiologic links in exercise intolerant
PASC, a task uniquely within our team’s expertise. Angiotensin-converting enzyme 2 (ACE2) is not just an entry
receptor for SARS-CoV-2 but also an enzyme with a protective function through regulation of the renin-
angiotensin system. Studies have shown that a high level of plasma ACE2 is associated with an increased risk
of SARS-CoV-2-related mortality. Our preliminary data showed that the catalytic activity of increased plasma
ACE2 was significantly impaired in the exercise intolerant PASC patients, and closely correlated with reduced
exercise capacity as measured by peak oxygen consumption evaluated during iCPET. Furthermore, to study the
pathogenic mechanism of exercise intolerance in PASC, we established a novel PASC mouse model. In this
model, we observed the persistence of the SARS-CoV-2 RNAs in lung microvascular ECs, impaired ACE2
activity, chronic pulmonary inflammation, along with a significant reduction in exercise capacity. Thus, we
hypothesize that dysfunctional ACE2 shed from pulmonary ECs is a major driver for exercise intolerance in PASC
and an engineered solube ACE2 with enhanced ACE2 activity will improve exercise capacity of PASC. To test
our hypotheses, we will investigate the predictive value of ACE2 activity as a clinical biomarker and assess its
association with exercise capacity over 12 months in PASC patients in Aim 1. We will define an engineered
soluble ACE2 with enhanced ACE2 activity as an innovative therapeutic intervention to improve exercise capacity
and vascular function in the PASC mouse model in Aim 2. Furthermore, we will explore the mechanism of ACE2
dysfunction shed from the pulmonary vasculature in Aim 3. If successful, we will identify a diagnostic and
therapeutic paradigm urgently needed for PASC patients experiencing exercise intolerance, and remediate the
deficient response to this global public health threat.

Public health relevance
Project Narrative Long-COVID, also called post-acute sequelae of COVID-19, is a growing health concern. Right now, it's challenging to figure out who might be at risk or how to help. In our plan, we want to show that a problem enzyme released from blood vessels during prolonged COVID-19 can cause ongoing inflammation in the lung, leading to exercise fatigue in Long-COVID. We also want to prove that a new medicine that targets this enzyme can be a good treatment for Long-COVID.